IGF::OT::IGF TASK ORDER 25: SUPPORT FOR CANCER CARE DELIVERY IN A RAPIDLY CHANGING HEALTHCARE SYSTEM CONFERENCE

The Health Delivery Research Program (HDRP) has meeting support needs related to the NCI/ECRI conference, Cancer Care Delivery in a Rapidly Changing Healthcare System. This conference will take place from November 17-18, 2015 at the Omni Shoreham Hotel in Washington, DC.